Localizing and modulating competing memories of fear and safety in the human brain

PROJECT SUMMARY. Pathologies characterized by excessive fear and anxiety are the most common mental
illness with a 12-month prevalence estimate of about 40 million American adults. The primary treatment for
anxiety and stress-related disorders is exposure therapy, which is informed by theoretical and technical aspects
of Pavlovian extinction. However, extinguished behaviors are prone to relapse under a variety of circumstances.
Further, clinical research reveals serious deficits across a host of psychiatric conditions in the ability to form and
retrieve extinction memories, which likely contributes to relapse following extinction-based therapies.
Accordingly, there is strong motivation to better understand how extinction memories are encoded, stored, and
expressed so as to bolster the strength and generalization of clinical treatment. Pioneering research in rodents
reveals that fear conditioning and extinction generate separate and measurable memory traces within and across
discrete brain regions. Whether such an organization exists in the human brain is unknown. More precise
knowledge on how threat and safety memories are represented and interact in the human brain will advance
innovative treatments for pathological anxiety that are built on the neuroscience of learning and memory. The
goal of this research is to better understand how competing memories of fear and safety are formed, stored, and
retrieved in the human brain. To build directly on mechanistic insights from animal models, we utilize Pavlovian
fear conditioning and extinction in adult humans during functional magnetic resonance imaging (fMRI). The
research leverages advances in multivariate pattern analysis techniques, and integrates theoretical and technical
advancements of fear extinction research from animal models with computational approaches developed to
study human memory. Each study includes healthy adults and individuals with posttraumatic stress disorder
(PTSD), as linking advances in fear extinction research to the pathophysiology of PTSD can have direct benefit
to exposure therapy—the gold-standard treatment based on the principles of extinction. We also evaluate
extinction memory at 24-hours and again at 1 month. Assessing long-term extinction retrieval in humans is
extremely rare, but consistent with diagnostic criteria for assessing PTSD, and thus furthers the bridge to
translational relevance. Aim 1 attempts to identify separate and stable memory traces of fear and extinction in
by identifying the correspondence (overlap) between neural activity related to the formation and retrieval of fear
and extinction over time. Aim 2 decodes a multivariate neural signature selective to the contextual encoding of
extinction memories. Aim 3 uses a non-pharmacological behavioral strategy to modulate the strength of
extinction to determine how enhanced fear extinction affects multivariate neural signature of extinction memory
retrieval over time. These findings have the potential to establish new risk and resilience factors for anxiety and
stress-related pathologies, and may ultimately contribute to innovative neuroscience-based treatments for
psychiatric conditions marked by excessive fear and the inability to regulate unwanted emotional responses.

Public health relevance
PROJECT NARRATIVE In psychiatric disorders characterized by severe stress and anxiety, memories of safety are more difficult to learn and remember than memories of threat, perhaps explaining relapse after therapy. The proposed research uses multivariate pattern analysis of neuroimaging data to localize the neural representation of threat and safety memories in the human brain. This research could lay the theoretical groundwork for more effective clinical treatments for anxiety and stress-related disorders.